The Impact of Parental Longevity on Brain Health - and the Influence of Physical Functions and Genetics

Parent Grant (R01AG062659)
Specific Aims: Trajectories and modifiable risk factors of brain, gait, and cognitive decline
in aging and pre-dementia
ABSTRACT:
Clinical gait abnormalities are present in about 35% of community-dwelling older adults in the US,
and accelerated gait decline is associated with many adverse physical and cognitive outcomes -
including falls, disability, cognitive decline, and dementia. Such outcomes not only reduce the
quality of life of affected individuals, their families, and friends, but also leads to increased health
care costs. Our research aims to understand the interrelationship between brain aging, gait
decline, cognitive decline, and dementia – and will guide future development of interventions for
maintaining gait and cognition in aging and early dementia. Accelerated gait decline is associated
with an increased risk for cognitive decline, Alzheimer’s disease, and related dementias (1-9). A
common explanation of such associations is that gait and cognition rely on shared neural
substrates that are affected by both normal and dementia-related aging (10-13). Yet, the neural
substrates that link gait, cognition, and dementia are not well-understood. A better understanding
of these neural substrates – and how they are influenced by potentially modifiable risk factors of
dementia such as poor social networks or support (14, 15) – is important for developing effective
therapies for maintaining gait and cognition in aging and early dementia. We propose to compare
trajectories of functional and structural brain changes, gait decline and cognitive decline in older
adults who are cognitively normal, and those in the early stages of cognitive decline.
Aim 1: Compare trajectories of functional and structural brain aging, gait decline and
cognitive decline.
H.1a: Functional and structural brain changes, mainly in supplementary motor area, insula, and
PFC, precede (are steeper or have earlier change points than) gait and cognitive decline.
H.1b: Functional brain changes related to gait and cognitive decline precede structural brain
changes.
Aim 2: Examine the influence of MCR on functional and structural brain changes, gait, and
cognitive decline.
H.2: Trajectories of functional and structural brain changes, mainly in supplementary motor area,
insula, and PFC, are steeper/have earlier change points in those with MCR than non-MCR.
Aim 3: Examine the role of social networks on functional and structural brain changes,
gait, and cognitive decline.
H.3: Trajectories of functional and structural brain changes, mainly in insula and PFC, gait and
cognitive decline are steeper/have earlier change points in those with small social networks than
large social networks.

Public health relevance
Project Narrative: This proposal will investigate healthy aging by utilizing parental longevity as model to identify structural and functional differences in the brain. It will also assess the role of physical function and genetics on the association between parental longevity and brain architecture. This proposal has the potential to understand the divergence between normal, healthy brain aging and cognitive impairment and to provide interventions for improved treatment and decrease the impact of age-related diseases.